ORAL ZOLOLRESTAT IN NORMOTENSIVE, TYPE I DIABETICS WITH INCIPIENT NEPHROPATHY

This study will evaluate the efficacy of Zopolrestat, a potent, reversibile, noncompetitive inhibitor of aldose reductase in preventing complications in Type I diabetics with incipient nephropathy.